DiversitySupp-ONES-Prenatal Phthalate Exposure

Project Summary
Spontaneous preterm birth (sPTB) comprises the majority of preterm births (60%) and is a leading case of
newborn morbidity and death and a predictor of adverse health outcomes. Despite its high prevalence, there is
a limited understanding of how the in-utero environment contributes to the etiology of sPTB. Phthalates are
ubiquitous endocrine disrupting chemicals that induce gene expression and physiological changes within the
placenta. Epidemiological studies identify a consistent positive relationship between prenatal phthalate
exposure and preterm birth. The goal of this study is to develop placental molecular signatures that can be
used to mechanistically link prenatal phthalate exposure and sPTB. Placental molecular signatures can explain
functional differences related to sPTB and identify targets for clinical and therapeutic interventions, including
modifiable risk factors such as environmental exposures. Our research team has generated the largest
placental transcriptomics dataset to date (N=760 samples) and has used this to develop transcriptomic
signatures of prenatal phthalate exposure and sPTB. This study will expand our existing transcriptomic
signatures to include microRNAs, which are essential to a complete molecular signature because they are
highly stable, have been linked to a number of environmental exposures, and are secreted into maternal
circulation where they may serve as biomarkers. Candidate microRNA studies have identified correlations
between prenatal phthalate exposure and expression of placental microRNAs, but a comprehensive
assessment is needed to fully understand the role of placental microRNAs in phthalate mediated toxicity.
Moreover, despite the potential importance of placental microRNAs as a biomarker of sPTB, there has not
been a comprehensive analysis. In this proposal, we seek to fill these research gaps and apply innovative
computational biology strategies with rigorous epidemiological approaches to gain insight into the mechanistic
links between prenatal phthalate exposure, placental function, and sPTB. In aim 1, we will generate microRNA
data on placental samples and use this to generate a signature of prenatal phthalate exposure. We will use the
matched microRNA-mRNA sequencing data to construct a global placental microRNA-mRNA network, which
we will apply to identify connections between microRNAs and genes whose placneta expression is associated
with different phthalate metabolites. In Aim two, we will develop a multi-omic molecular signature of sPTB
using our placental microRNA-mRNA network. In aim 3, we will examine the role of the placenta as a
mechanistic link between prenatal phthalate exposure and sPTB by interdisciplinary strategies including an
integrated pathway analysis and a formal mediation analysis. Findings from this study will inform chemical
toxicological risk assessment and policy to reduce health impacts due to phthalate exposure in pregnancy.
microRNA signatures of sPTB may serve as functional biomarkers of sPTB since they can be secreted into
maternal circulation and be targets for clinical and therapeutic intervention in the future.

Public health relevance
PROJECT NARRATIVE Spontaneous preterm birth is a highly significant but understudied perinatal outcome that comprises the majority of premature births and has been linked to prenatal exposure to environmental chemicals, including phthalates. This study will investigate the mechanistic link between prenatal phthalate exposure, placental dysfunction, and spontaneous preterm birth using multi-omics data generated in the placenta. Findings from this study will inform chemical toxicological risk assessment and policy, as well as aid in the development of potential biomarkers of spontaneous preterm birth.